Translational approaches to unravel organ-specific microvascular endothelial responses in sepsis.

Translational approaches to unravel organ-specific microvascular endothelial responses in sepsis.
PROGRAM SUMMARY:
Sepsis is defined as life-threatening organ dysfunction caused by a dysregulated host response to an
infection and is associated with high mortality. Systemic inflammation and endothelial activation with resultant
microvascular leak, thromboses, and hypoxic tissue injury are hallmarks of sepsis. Yet, in over 100 trials, drugs
aimed at modulating cascades of inflammation and coagulation have not proven to be efficacious. The primary
reason for this failure is attributed to clinical and biological variability among critically ill patients. More recently,
high-throughput approaches including gene-expression profiling have shown promise in disentangling patient-
level heterogeneity in the host immune response. In contrast, sampling challenges coupled with cell and organ
level heterogeneity have impeded a similar understanding of the host endothelial response. It follows that
translational approaches that shed light on human microvascular pathobiology may lead to the discovery of
targeted therapies that restore tissue homeostasis and shift sepsis care paradigms toward organ recovery.
My research program seeks to address key knowledge gaps that currently impede scientific progress
through projects spanning 3 domains. 1) DISCOVERY: The endothelium in patients remains inaccessible.
Moreover, while endothelial heterogeneity and organ-specificity are increasingly recognized, their contribution
to the evolution of organ dysfunctions remains poorly understood. To address this, we will enrich circulating
endothelial cells from whole blood of children with septic shock with the primary objective of developing a
transcriptomic atlas at single-cell resolution. By comparing signatures of circulating endothelial subsets from
patients, relative to published datasets of tissue-resident endothelial cells, we will identify organ-specific targets
for future hypotheses testing. 2) DISEASE MODELS: The reductionist nature of current preclinical models has
impeded translation of basic science discoveries into improved sepsis outcomes. Thus, there is a significant
need for advanced disease models that recapitulate human sepsis pathobiology. My laboratory will develop
human induced pluripotent stem cell derived microvascular organoids and stimulate them with biomarker risk-
stratified plasma from patients to model endothelial dysfunction in human sepsis. Our models are expected to
serve as robust testbeds for hypotheses testing. 3) DISEASE MECHANISMS: Finally, we will establish cutting-
edge CRISPR-Cas9 gene-editing tools in vitro to efficiently study the mechanistic basis of candidate genes
identified through our studies. This transdisciplinary proposal is made feasible by a long-standing study of
pediatric septic shock with unparalleled access to biospecimens, institutional shared resources, and ongoing
collaborations with a rich network of scientists with technical expertise. The approaches established through
this proposal are expected to enhance our understanding of organ-specific microvascular endothelial
responses and hold potential to inform development of precision therapies. Funding through the NIGMS ESI-
MIRA will thus maximize my laboratory’s research efforts to improve the outcomes of children with sepsis.

Public health relevance
Translational approaches to unravel organ-specific microvascular endothelial responses in sepsis. NARRATIVE: My laboratory is focused on understanding how injury to blood vessel cells contributes to organ damage in children with sepsis –a life-threatening condition caused by an infection. By detailed study of free-floating blood vessel cells and by treating miniature blood vessel organs in petri dishes with plasma collected from children with sepsis, we seek to identify genes that lead to organ damage. Our studies may lead to the discovery of medicines that can help recover from organ damage and help save the lives of very sick children with sepsis.